PLASMA CYTOKINE ANALYSIS TO PREDICT BACTEREMIA IN CHILDREN

This study evaluates the different protein levels in the blood of children with fever to help predict more accurately and quickly the source of the fever.